Genome Editing

!
GENOME EDITING SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
Mouse models of human cancer are instrumental in understanding tumorigenesis. Advances continue to be
made that allow better understanding of the mechanisms of tumor development, which leads toward the
identification of new diagnostics and therapies. The Genome Editing shared resource at Rutgers Cancer
Institute of New Jersey (CINJ) was established in 2016 as a consortium managed shared resource whose
purpose is to provide a centralized laboratory for the generation and preservation of mouse research models
and creation of custom genome edited cell lines.
The services offered by the Genome Editing shared resource ensure that investigators across the consortium
are equipped to make scientific breakthroughs and speed research into mechanisms of cancer initiation,
progression and treatment using genetically engineered mouse models (GEMMs) and genetically modified
human and mouse cell lines. The considerable experience and technical expertise of the managing and
scientific directors are also a valuable resource made available to investigators. Moreover, Genome Editing
offers cryopreservation of research mouse models to safeguard against devastating loss of investigators’
valuable GEMM lines. Almost all of the procedures conducted by the shared resource require a high degree of
technical expertise and equipment not readily available to individual laboratories.
In addition to its service functions, the Genome Editing shared resource plays an important intellectual role in
the development and pursuit of mouse-oriented research projects and the application of genome editing
throughout the CINJ consortium. The shared resource also engages in the development of new approaches
and methodologies in genome editing to better serve its users.